Determination of P21 upstream signaling in the toxicity of MC and DMC DNA interstrand crosslinks (Student: Melissa Rosas)

Summary: The overarching goal of the parent proposal for this “research supplement to promote diversity in health-related research” is to investigate the relationship between the structure of stereoisomeric DNA Interstrand Crosslinks (ICLs) formed by Mitomycin C and Decarbamoylmitomycin C and the molecular mechanisms of these drugs. Mitomycin C (MC) is an anticancer drug currently used to treat stomach, anal and lung cancers. The stereochemical configuration at C1?? of MC major ICL is R (?-ICL). In contrast, Decarbamoylmitomycin C (DMC), a derivative of MC lacking the O10 carbamoyl group, generates the S stereoisomeric ICL (?-ICL). The scientific premise of the proposed research is that ICLs constitute the molecular basis for the cytotoxic effects of mitomycins. The central hypothesis is that differences in the local DNA structures of the ? and ?- ICLs are responsible for the distinct biochemical responses triggered by MC and DMC. In particular, contrary to MC, the DNA-adducts generated by DMC treatment (?-ICL) rapidly activate a p53-independent cell death pathway. Thus, the study MC-DMC provides an ideal model for identifying structural features determining the cell signaling outcome in the presence or the absence of a functioning p53 pathway. Since p53 tumor suppressor is frequently mutated in human cancers, the need to identify drugs and pathways that induce cell death or cell cycle arrest independently of p53 deserves substantial attention. Within the scope of the parent project, this supplement to promote diversity in health-related research will be used to train the candidate, Melissa Rosas, to: 1: Synthesize oligonucleotides containing ?/? ICLs; 2: Transfect cells with the ?/? ICLs and extract proteins; 3: Validate upstream signaling molecules, such as ATR/BRCA1, involved in the p21 signaling pathway triggered by the presence of either the ? or ? ICL. Melissa’s long-term goal is to become a clinical pathologist. The training and activities proposed will improve Melissa’s chances to access medical schools by fostering crucial technical and professional skills. As Melissa gains new exposure to the research environment, she will become more comfortable interacting with other scientists and sharing her work. This increased confidence will be an asset during medical school interviews and presentations. In order to further enhance Melissa’s competitiveness to access medical programs, she will present her research findings at conferences and publish at least one manuscript. She will also receive career advisement from Dr Edgardo Sanabria-Valentin, the PRISM Associate Program Director. As the Pre-Health Career Advisor, he will assist Melissa in considering long-term career goals and the skills needed to achieve them as well as in preparing her medical school application material.

Public health relevance
A lot of chemotherapeutic agents function through the activation of p53 and other apoptotic pathways, however at least 50 percent of all cancers do not have a functional p53-pathway. The proposed research will reveal molecular and cellular networks up or down regulated in the p53- independent mode of cell death triggered by DMC DNA adducts. Results may be used for personalized treatment consideration based on the genetic makeup of tumors, particularly tumors lacking the p53 transcriptional factor.